Tri-Institutional TRAC Basic Science Core

ABSTRACT
Efforts to control the tuberculosis (TB) pandemic depend on a close and bidirectional integration of basic and
clinical research because TB is a human-only disease. Archaeological DNA evidence further indicates that
humans constitute Mycobacterium tuberculosis’ (Mtb) only known host and reservoir, making knowledge of the
fundamental biology of TB dependent on training in a both a diverse and specialized network of disciplines and
technologies. The Basic Science Core, led by Drs. Sabine Ehrt and Mike Glickman, seeks to meet these
needs by providing new, and new to TB, investigators (NI/N2TB) access to technical expertise and resources
to pursue innovative multidisciplinary lines of investigation while simultaneously facilitating their entry into the
field of TB research. To do so, this core will provide structured mentorship from: senior TB investigators at
Weill Cornell, Memorial Sloan Kettering and Rockefeller University in seven areas of basic science relevant to
TB research (“OMICS” technologies, genetic screening technologies, TB mouse models, mycobacterial
genetics, molecular biology and biochemistry, human genetics and immunology, drug development and
chemistry, and bioinformatics and data analysis); and technical experts from the labs of these faculty to
provide hands-on training in these seven areas. These senior investigators will also facilitate the networking of
these new, and new to TB, investigators with pre-existing collaborators in their respective fields. The
assembled faculty are leaders in the mycobacterial subfields of bacterial genetics, animal models, immunology,
metabolomics, and genetic screening and have an extensive track record of mentoring and interdisciplinary
collaboration.
The Basic Science Core will operate in close collaboration with the Developmental Core and offer 2 funded
training pathways: the “Training to Independence Pathway” and the “Specialized Technology Training
Pathway”. The goal of the former is to help NIs secure an independent faculty position and their first R01 and
will involve a package of mentorship, career development, technical experts and access to basic science
resources (animal facilities, genetically modified Mtb libraries, mass spectrometry, etc.). The goal of the latter
pathway is to provide NIs, N2TB, and other investigators with focused support and involve technical experts for
specialized skills acquisition and/or technology transfer and access to basic science core resources.
Together, these activities will enable the Basic Science Core to meet the overarching goals of this TRAC
program to: 1) increase the number of NIH funded investigators conducting basic science and translational
research in TB, and 2 foster multidisciplinary TB research.